An Anticoagulation-Free Artificial Placenta Device

Project Summary/Abstract
Extremely preterm (EPT) infants have a high rate of mortality and morbidity, primarily due to the
underdevelopment of the lungs. When born before 23 weeks of gestation, infants are generally considered non-
viable, and have no options to keep them alive. Between 23-27 weeks, these infants still have high morbidity
and mortality, with survival to discharge without major morbidity varying between 43% at 27 weeks to 2% at 23
weeks. An artificial placenta is an adaptation of extracorporeal membrane oxygenation (ECMO) designed for a
premature infant and performs extracorporeal gas exchange. An artificial placenta simulates intrauterine
physiology and may enable continued normal development outside of the uterus. However, current artificial
placenta oxygenators in development use hollow-fiber membrane (HFM) technology, which is limited by high-
dose anticoagulation requirements and large priming volumes. Anticoagulation is especially dangerous in EPT
infants, who already have high rates of intracranial hemorrhage due to their underdeveloped cerebral
vasculature.
The SiMOx-AP is a novel microfluidic artificial placenta oxygenator designed to operate without anticoagulation,
thus overcoming a key barrier to clinical translation of an artificial placenta device. It is based on breakthrough
semiconductor silicon-based semi-permeable membranes made using microfabrication techniques. The rigid
and flat-plate nature of the silicon membranes overcome limitations of HFM and flexible microfluidic oxygenators.
In this R21, we will investigate the feasibility of a clinical-scale and anticoagulation-free SiMOx-AP device using
a combination of computational, benchtop, and preclinical in-vivo studies.

Public health relevance
Project Narrative Each year in the United States, 10,000 infants are born between 20 and 23 weeks of gestation, but cannot survive outside the womb due to their prematurity. An artificial placenta would allow the infant to grow and develop in an environment similar to the uterus, offering a treatment option to these patients. We are developing a novel artificial placenta device designed to be small and efficient as well as operate without anticoagulation, improving outcomes for extremely preterm patients.